Functional maturation of interneurons that mediate the vestibulo-ocular reflex - Renewal - Resubmission - 1

PROJECT SUMMARY / ABSTRACT
Deficits in vestibular function severely impact quality of life for 5% of children, 1/3 of Americans over 40, and
lead to falls, a major cause of death among the elderly. Understanding how vestibular reflexes develop and
function is therefore profoundly important. Vertebrates stabilize their gaze with a highly conserved neural cir-
cuit consisting of 1) sensory afferents that sense instability, 2) projection interneurons that relay and transform
corrective commands to 3) extraocular motor neurons. Vestibular interneurons show considerable heterogene-
ity in their responses to instability. Correlative studies of functionally-defined interneuron subtypes have shaped
our understanding of vestibular signal processing, motor learning, and recovery after injury. However, we know
comparably little about how vestibular interneurons develop. In cortex, thalamus, and spinal cord, molecular
characterization of development enabled subtype-specific targeting, loss-, and gain-of-function experiments.
These tools revolutionized our understanding of neural circuit function. Here we propose a similar approach to
understand interneurons responsible for the vestibulo-ocular reflex.
In the past period, we discovered that vestibular interneuron birthdate anticipates identity (i.e. nose- up/nose-
down sensitivity and eyes-up/eyes-down connectivity). Here, we will use birthdate as a handle to differentiate
subtypes of vestibulo-ocular reflex interneurons. Specifically, we will determine if/how birthdate and sensory
experience shape an interneuron’s transcriptional identity, sensory selectivity, and influence on behavior. By
illuminating how fundamental properties of vestibular interneuron subtypes emerge, our work stands to make a
significant contribution to our understanding of normal and disrupted balance circuit development.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because discovering the principles that permit normal de- velopment and function of balance circuits is expected to increase understanding of the mechanisms respon- sible for vestibular pathologies and associated balance dysfunction. Therefore, the proposed research is relevant to the part of the NIH’s mission to increase fundamental knowledge of the mechanisms of diseases, disorders, and dysfunctions that impair health.